Novel metrics of brain dynamics in Alzheimer’s disease

PROJECT SUMMARY/ABSTRACT
Alzheimer’s disease (AD) is a progressive neurological disorder that adversely affects cognition and daily
functioning in older adults. Functional MRI is a non-invasive and widely available neuroimaging tool that can be
used to identify early manifestations of AD, which can then be used as a complimentary biomarker to enrich
clinical trials with those patients most likely to decline. Recent investigations have suggested that the core brain
abnormalities in AD may not arise from structural or even functional connectivity, but rather the timing of brain
activity. Abnormal brain timing is an intuitive mechanism for decreased cognitive flexibility, and may serve as a
biomarker for mild cognitive impairment (MCI) and AD. The purpose of this study is to investigate how changes
in the temporal duration of functional connectivity are related to MCI and AD. The specific aims are: 1)
Characterize the temporal aspects of functional connectivity in cognitively intact individuals and those with
cognitive impairment (MCI and AD); 2) Examine the evolution of sustained and lag-based connectivity in
individuals with cognitive impairment and establish which biological and cognitive factors predict change; and 3)
Evaluate the predictive performance of sustained and lag-based connectivity as a biomarker for cognitive
impairment. This proposal is designed to facilitate the career development of Dr. Jace King in acquiring the
necessary training, practical experience, and knowledge to become a lead investigator in brain related
dysfunction associated with MCI and AD. To excel as an independent researcher, Dr. King will obtain research
skills in the following areas: 1) neuropsychological, neurobiological and clinical manifestations of AD; 2)
longitudinal study design and analysis; and 3) advanced statistical methods involved in machine learning with
an emphasis on how these tools can be used to conduct behavioral phenotyping. This research will be conducted
at the University of Utah and supported by a multidisciplinary mentorship team with collaborative experience but
distinct expertise. Dr. Duff (primary mentor) is an expert in the neuropsychological assessment of MCI and AD.
Dr. Foster (co-mentor) is an expert in the diagnosis and treatment of AD. Dr. Minoshima (co-mentor) is
internationally known for his discovery of early signs of AD and dissemination of diagnostic statistical mapping
technology. Dr. Phillips (co-mentor) has expertise in machine learning and advanced statistics. Dr. Zielinski’s
(co-mentor) expertise are in multimodal MRI analysis and longitudinal study design. Complimenting this team is
a dedicated team of consultants with expertise in AD diagnosis and treatment, advanced statistical modeling,
and advanced fMRI data analysis. Successful completion of this award will provide the applicant with the
background and training necessary to pursue an R01 application to investigate longitudinal brain function in
aging populations. The proposed research makes significant contributions to the field as it has the potential to
provide novel insights in the cognitive neural mechanisms underlying AD, which will aid in the implementation of
targeted intervention and prevention efforts.

Public health relevance
PROJECT NARRATIVE Alzheimer's disease (AD) is a progressive neurological disorder that adversely affects cognition and daily functioning in older adults. This proposal seeks to better understand the association between alterations in dynamic functional brain activity as it relates to biomarkers and decreasing cognition in individuals with mild cognitive impairment and Alzheimer’s disease, as well as cognitively intact seniors. This project will inform clinical trials by predicting biomarker status based on dynamic functional connectivity in older adults with and without cognitive impairment.